CORE--CENTRAL MEDIA PREPARATION FACILITY

The Core Media Preparation Facility is responsible for the preparation of high quality, chemically-defined bacteriological and tissue culture media necessary for cell growth research projects at MSKCC. The Facility can produce over 160 different types of culture media.